Project 3: Enhanced Costimulation Blockade to Achieve Clinically Relevant Heart Allograft Tolerance

PROJECT SUMMARY / ABSTRACT
The unifying goal of this Program is to design new and innovative strategies that achieve clinically-relevant
heart allograft tolerance in 2-month-delayed tolerance induction protocols which induce either transient or
durable mixed chimerism. The PI of this Program application has recently developed novel protocols that
have, for the first time, achieved long-term, stable tolerance of fully MHC mismatched hearts in cynomolgus
monkeys. This remarkable result was attained in heart recipients by combining a transient mixed chimerism
protocol with donor kidney co-transplantation. Recent pilot studies have demonstrated the feasibility of
replacing the previous requirement for donor kidney co-transplantation with approaches that both inhibit CD8
effector/memory T cells and enhance host regulatory T cells. Project 3 will build on the clinically-applicable
heart tolerance induction platform developed by the Madsen team (2-month D-Protocol; presented in the
Overview and in detail in Project 1) and the Pierson/Azimzadeh lab's extensive experience with dual
costimulation pathway blockade in NHP heart allograft models. We will test whether enhanced costimulation
pathway blockade (αCD2 with αCD154 and/or αCD28) can replace the requirement for renal co-
transplantation while evaluating αCD2 (Aim 1) or inhibition of JAK 1/3 (Aim 2) or Bcl-2 (Aim 3) as alternative
and potentially complementary approaches to deplete or inhibit tolerance-resistent effector memory T cells
(TEM) cells and reduce toxicity (eliminate the need for αCD8 and reduce or eliminate host total body irradiation
(TBI)) in the 2-month D-Protocol. Guided by initial results, we will also deploy TReg-supportive treatments (from
Project 1) and radiation-free conditioning using αCD117-Amanitin antibody drug conjugate (from Project 2)
with αCD2-based enhanced costimulation blockade, aiming to reduce or eliminate the need for radiation and
thereby reduce toxicity. Core A will elucidate the cellular and molecular mechanisms associated with success
or failure to consistently induce tolerance in the three coordinated but distinct Project 3 Aims, and enable
mechanistically informative comparisons between results from distinct but closely aligned Aims in Projects 1
and 2. We anticipate that one or more Aims in Project 3 will generate innovative, effective, and safe tolerance
protocols that will be ready for clinical trials in heart recipients by the end of the funding period, and enhance
our understanding of tolerance induction in a clinically relevant context.